INFLUENCE OF IGF I AND ESTROGEN ON SKELETAL TURNOVER IN AGED WOMEN

This project studies the effects of recombinant human IGF-1 on skeletal turnover in postmenopausal osteoporotic women. The effects of supplemental estrogen administration on IGF-1 skeletal actions will be determined.